Community Health Educator Supplement to Cancer Center Support Grant

Although generally affluent, Connecticut is characterized by extreme differences in socio- economic status between urban and suburban/rural populations. Non-white populations live primarily in poor urban areas. These are the areas in which we observe disparities in cancer screening and access to clinical trials. The objective of this proposal is to complete the work that is associated with 2 National Outreach Network (NON) initiatives: 1) Increase knowledge about and awareness of clinical trials in at-risk communities and facilitate access for cancer patients who are underrepresented in the YCC clinical trial portfolio; 2) Increase colorectal cancer (CRC) screening in the YCC catchment population by implementing Phase 2 of the NCI’s Screen to Save (S2S) program. Adapting to the constraints associated with COVID-19 pandemic, including working remotely, revised Specific Aims are: 1) Launch Virtual Clinical Trial Education Intervention a. Complete a minimum of 150* pre- and post- assessments from target communities b. Connect interested parties to Yale Clinical Trial Office using existing infrastructure; complete follow up to evaluate linkages to care 2) Launch Virtual Colorectal Cancer (CRC) Screening education intervention a. Complete a minimum of 150* pre- and post- assessments from individuals who are due or overdue for CRC screening in a large primary care setting (Cornell Scott Hill House Health Center [FQHC]) b. Complete follow up surveys at 3 and 6 months to ascertain compliance and intention to screen c. Collect follow up information from EPIC at one year to assess uptake, completion, and clinical follow through of CRC screening Transition to virtual implementation has required new strategies: 1) creation of CAPE: Cancer Action Prevention Engagement, a virtual infrastructure using social media and website for engagement, outreach, education, & research; 2) Build out of 2 REDCap databases, adapted written surveys for REDCap, in Spanish and English, REDCap self-training. A novel adaptation is that Aim 2 (S2S, Phase II) is embedded in a larger CRC screening implementation study testing the uptake of screening in this intervention arm (education) compared with 3 other evidence-based interventions to increase CRC screening.

Public health relevance
The objective of this Community Health Educator (CHE) supplement to the Yale Cancer Center (YCC) P30 grant is to complete work associated with 2 NCI National Outreach Network (NON) initiatives: 1) Increase knowledge about and awareness of clinical trials in at-risk communities; and 2) Increase colorectal cancer screening by implementing Phase 2 of the NCI’s Screen to Save (S2S) program. All activities associated with this work will be adapted for virtual implementation. These initiatives will be critical to our mission to address cancer disparities in the YCC catchment population.